Molecular Center of Health and Disease

Abstract
The objective of the Notice of Special Interest (NOSI): Administrative Supplements for Equipment Purchases for
Select NIGMS-Funded Awards (NOT-GM-24-021)] is to provide funds “intended for the purchase of needed
equipment that will enhance user access to and/or the impact of the resource” for centers, resources and core
facilities. The mission of the Molecular Center of Health and Disease (MCHD)-COBRE (1P20GM144041) is to
employ innovative molecular and physiological approaches to study health, onset and progression of disease,
and interaction with pathogens, with the goal of understanding the breadth of information from the molecular
level to the whole organism. The MCHD provides investigators access to several cutting-edge biomedical
research tools through two central research cores: Core B: Omics and Gene-Editing Core and Core C: Research
Computing, Bioinformatics, and Biostatistics. The focus of these cores is to generate cutting-edge omics
datasets, along with high level molecular insight into RPL, PPL, and other investigator research projects
associated with the MCHD-COBRE. The MCHD-COBRE is not currently supporting instrumentation required for
physiological studies as most of our access to this type of instrumentation is provided through interactions with
other institutional supported cores and COBRE (as to not duplicate services). However, there is an immediate
need to replace an instrument that will have broad usage for the MCHD and other COBRE. Specifically, our IVIS
Imaging System, which was originally purchased in 2009 (only instrument at UMMC or State), has become
outdated and desperately in need of an update due to age, frequent breakdowns, and technical limitations. We
request funds to purchase AmiHTX High Efficiency In Vivo Imaging System instrument to allow for higher
resolution imaging, additional capabilities including x-ray imaging, enhanced wavelength detection, and data
analysis capabilities. This instrument will serve both current and future RPL and PPL, provide a vital resource to
the UMMC research community that will be highly leveraged for the stated goal of the MCHD, and serve a goal
of IDeA funding to build institutional infrastructure for a high impact resource.

Public health relevance
Narrative The mission of the Molecular Center of Health and Disease (MCHD)-COBRE is to employ innovative molecular and physiological approaches to study the health and disease continuum. The purchase of new AmiHTX in vivo animal imaging system will replace the current 15-year-old IVIS Spectrum Imager to allow for higher resolution imaging and data analysis capabilities that will help achieve the mission and goals of the MCHD.